Characterization of Serum Extracellular Vesicles with Human Age

We characterized EV attributes across selected age groups of participants from the population based, longitudinal study, Healthy Aging in Neighborhoods of Diversity across the Life Span (HANDLS) in LEPS. We analyzed circulating plasma EVs from the HANDLS study using both a cross-sectional and longitudinal approach to address age-related changes in community-dwelling individuals. This sub-cohort consisted of 30 young individuals, 30 middle-aged individuals, and 14 old individuals, who had contributed plasma at two different time points (Visit 1 and Visit 2) approximately 5 years apart. The participants in each age group were matched by race and sex. We isolated EVs from plasma using a precipitation method and analyzed size and concentration using Nanoparticle Tracking Analysis and linear mixed-model regression. We found that EV concentration decreases with advancing age. We also analyzed whether EV concentration was related to demographic and anthropometric measures. BMI and smoking status were significantly associated with EV concentration only at visit 2. There were no significant changes in EV concentration with sex or race. The major finding that EV concentration decreases with advancing age was further explored by examining uptake of EVs by immune cells. EVs from older individuals were more readily internalized by B cells and increased MHC-II expression on monocytes compared with EVs from younger individuals, indicating that the decreased concentration of EVs with age may be due in part to increased internalization. EVs activated both monocytes and B cells, and activation of B cells by LPS enhanced EV internalization. We found a relative stability of EV concentration and protein amount in individual subjects over time. Our data provide information towards establishing a profile of EVs with human age, which will further aid in the development of EV-based diagnostics for aging and age-related diseases. We found that several immune-related antigens like MUCIN16, MUC1, NY-ESO, CD14 and PDL increase with age. The reduction in EV concentration may be a consequence of aging-related phenotypic changes like cellular senescence or part of altered intercellular signaling; both are important hallmarks of aging. EVs may be part of the aging mechanism and may change because of aging-related mechanisms and thus serve as biological aging indicators. While the current study shows that EVs change with age, further research is required to clarify their role in aging. As a follow-on study we examine the relationship between EVs and the presence of diabetes and pre-diabetes. To address this, we have designed a longitudinal sub-cohort of HANDLS that consists of 58 participants who have donated plasma at two time points approximately 5 years apart. Of these 58 participants, 19 were euglycemic at both time points, 19 participants were euglycemic at time point 1 and developed type 2 diabetes mellitus by the second time point and 20 were pre-diabetic at time point 1 and diagnosed with diabetes mellitus at time point 2. Individuals in this sub-cohort have been matched on obesity status. we designed cross-sectional and longitudinal cohorts of euglycemic, pre-diabetic and diabetic participants. In our recent publication in Diabetes (Freeman DW, Noren Hooten N, Eitan E et al 2018) diabetic individuals had significantly higher levels of EVs in their circulation than euglycemic controls. Using a cell-specific EV assay, we identified that erythrocyte-derived EVs are higher with diabetes. We found that insulin resistance increases EV secretion. Furthermore, the levels insulin signaling proteins were altered in EVs from individuals with high levels of insulin resistance and -cell dysfunction. Moreover, EVs from diabetic individuals were preferentially internalized by circulating leukocytes. Cytokine levels in the media and in EVs were higher from monocytes incubated with diabetic EVs. Microarray of these leukocytes revealed altered gene expression pathways related to cell survival, oxidative stress and immune function. Collectively, these results suggest that insulin resistance increases the secretion of EVs, which are preferential internalized by leukocytes and alters leukocyte function.